Oral Dissolvable Strips (ODS) as new pediatric and adult delivery mode of therapy for latent tuberculosis

PROJECT SUMMARY
Latent tuberculosis infection (LTBI) presents a critical global and domestic health challenge as the reservoir for
future TB cases, and approximately one-quarter of the world's population carries LTBI. It has been estimated
that 5-10% of these individuals are at risk of developing active TB disease during their lifetime. The US has seen
a reversal in its decades-long decline in TB cases, with a 5% increase in 2021 and an additional 3.7% rise in
2022, highlighting the urgent need for improved LTBI preventive treatment strategies. However, current pediatric
multi-drug formulations for TB pose significant infant-related and caregiver barriers to treatment adherence.
Caregiver barriers include the dosing complexities, such as multi-drug dosing difficulty in measuring precise
amounts of the liquid formulations and a low shelf-life. While effective, the recommended therapy for LTBI faces
significant challenges that limit its success, such as the availability of medication limited to large tablet forms
(swallowing difficulty in children), unpalatable taste (poor adherence), weight-based dosing requirements
(difficulty in precise dosing) and safety concerns (due to side effects of current therapeutics). The primary
medications for TB, Rifapentine (RPT) and Isoniazid (INH) are available only in large tablet forms that many
patients, especially children and those with swallowing difficulties, struggle to take. Oak’s INH-Oral dispersible
strip (ODS) and RPT-ODS are formulation options in which INH and RPT are encapsulated and captured with a
support matrix, that will revolutionize the management of TB. Oak’s ODS are developed through a proprietary
platform that is a key-enabling technology for the development of improved therapy and drug delivery for patients
of all ages. The Phase I project focused on the preliminary optimization of INH and RPT ODS and on generating
a proof of concept supporting the use of INH and RPT ODS through in vivo PK studies and demonstrating better
taste masking effect. In this SBIR Phase II, Oak will focus on optimizing the INH and RPT ODS. Initially Oak will
evaluate an efficient manufacturing process for ODS (Aim 1), wherein the ODS will be manufactured and
analyzed using three distinct approaches for a decrease in waste and manufacturing cost, including Knife-Over
Casting as Sheets, Twin Screw Extrusion as Continuous Ribbons, and Dose Extrusion as Discrete ODS. Further,
the encapsulated INH and RPT will be developed using optimization and spray drying methods (Aim 2). Lastly,
the manufactured INH and RPT ODS will be evaluated for their toxicity, PK, and stability profiles using in vivo
and in vitro methods (Aim 3), and prepare for an ANDA submission (Aim 4). These objectives ensure the final
products' therapeutic efficacy and commercial viability. The successful completion of this SBIR Phase II project
will be followed by preparation of Chemistry, Manufacturing, and Controls (CMC) documentation and conducting
process and product audits. This will pave way for initiation of Phase I clinical trials after clearance by FDA.

Public health relevance
PROJECT NARRATIVE Latent tuberculosis infection therapy faces significant challenges, such as the availability of medication in large tablet forms, unpalatable taste, weight-based dosing requirements and safety concerns. Oak Therapeutics has developed Rifapentine (RPT) and Isoniazid (INH) Oral dispersible strip (ODS) to overcome these limitations. After establishing proof of concept in their successfully completed SBIR Phase I, Oak will focus on increasing efficiency and decreasing the cost of the ODS manufacturing process which will pave way for IND filing.